Prion Protein in Alzheimer's Disease Pathophysiology

DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is one of the largest unmet medical need today. Epidemiologic data indicate that this need will mushroom in the coming decade unless new therapeutic options are identified. Pathological and human genetic studies have made substantial progress in supporting an Amyloid Hypothesis of AD and efforts to remove amyloid-Aβ (Aβ) immunologically, to block Aβ production by secretases and enhance Aβ degradation are advancing. However, a cell biological understanding of how Aβ is toxic for neurons has lagged. Recent studies have focused attention on soluble oligomers of Aβ as culprits in the disease process in both correlative and functional studies. The neuronal targets by which oligomeric Aβ mediates neuronal dysfunction are unknown but their identification would provide a novel pathway in drug development. In Preliminary Studies, we have identified the cellular Prion Protein (PrPC) as an Aβ-oligomer receptor by expression cloning. Synaptic responsiveness in brain slices from young adult PrP null mice is normal, but the Aβ-oligomer blockade of long-term potentiation (LTP) is absent. Thus, PrPC is a mediator of Aβ- oligomer induced synaptic dysfunction in vitro. Here, we will determine if the same molecular interaction plays a role in Aβ-induced memory dysfunction and neurodegeneration. We will determine the requirements for specificity in this interaction and explore downstream signaling pathways. Together, this work holds the promise of validating a novel therapeutic target for AD, one that is based not on Aβ levels but on preventing the deleterious actions of Aβ-oligomers on neurons through a specific binding site. PUBLIC HEALTH RELEVANCE: Alzheimer's disease extracts a massive health care burden but there are few treatments. Molecular studies have revealed that the amyloid- β peptide plays a key role in the brain malfunction. In this project, we test the hypothesis that cellular Prion protein mediates amyloid- β action. If validated, this hypothesis predicts that Prion protein will be a novel target for therapeutic development for Alzheimer's disease.

Public health relevance
Alzheimer's Disease extracts a massive health care burden but there are few treatments. Molecular studies have revealed that the amyloid-ss peptide plays a key role in the brain malfunction. In this project, we test the hypothesis that cellular Prion protein mediates amyloid-ss action. If validated, this hypothesis predicts that Prion protein will be a novel target for therapeutic development for Alzheimer's disease.